Scalable and quantitative chromatin profiling from formalin-fixed paraffin-embedded samples

PROJECT SUMMARY
Cellular function is regulated at the chromatin level by epigenomic features, including histone post-
translational modifications (PTMs) and chromatin-associated proteins (CAPs). The development of tools for
genomic mapping has ushered in a new era of epigenetic research, placing histone PTMs and CAPs in the
spotlight as novel biomarkers and therapeutic targets. Despite this progress, leveraging epigenomics for clinical
studies has been hindered by a lack of high-performance genomic mapping assays that are compatible with
formalin-fixed paraffin-embedded (FFPE) tissue, due to DNA damage that is incurred during the FFPE process.
FFPE is the gold-standard method for preservation and storage of clinical samples, with millions of samples from
diverse tissues and pathologies banked annually. While other FFPE sample-compatible chromatin mapping
assays have been developed, these approaches are unsuitable for clinical research due to limited sensitivity,
throughput, and / or resolution of specific chromatin features. As such, FFPE samples represent a largely
untapped goldmine for clinical genomic analyses. Development of a next-generation chromatin profiling assay
for FFPE samples would unlock access to disease-related epigenetic information within these clinical samples,
enabling novel biomarker discovery / validation and insights into therapeutical targeting of epigenomic targets.
To meet this need, EpiCypher is partnering with Dr. Kami Ahmad (Fred Hutchinson Cancer Research
Center) to develop CUTANA-FFPETM, a first-in-class low input genomic mapping tool for the analysis of FFPE
clinical samples. In Phase I, we developed the CUTANA-FFPE approach and successfully applied it to identify
tumor-specific regulatory elements in FFPE samples, demonstrating greatly improved performance compared to
existing assays and the transformative potential of this technology to advance clinical research. In Phase II, we
will prepare for commercial launch by developing standard operating procedures (SOPs) for processing FFPE
samples and validating the assay for diverse targets. Next, we will demonstrate the clinical utility of this novel
technology by expanding the approach to various tissue types, optimizing in situ target visualization, and defining
quality control parameters for banked FFPE samples. Finally, we will integrate data analysis pipelines into a
user-friendly and HIPAA-compliant bioinformatics portal, assemble CUTANA-FFPE beta kits, and apply
CUTANA-FFPE to map diverse targets in FFPE samples from diseased clinical tissue. Market availability of this
assay would be transformative for clinical research by enabling chromatin profiling in FFPE tissue, supporting
next-generation biomarker discovery and drug development.

Public health relevance
PROJECT NARRATIVE Genomic mapping of histone post-translational modifications and chromatin-associated proteins is a powerful approach to unlock new clinical insights, including biomarker discovery and drug development. Despite this, there is a lack of high-quality approaches to perform genomic mapping in formalin-fixed paraffin-embedded (FFPE) clinical samples, millions of which are banked annually. Here, EpiCypher is developing CUTANA- FFPE™, a revolutionary assay that will enable genomic mapping in FFPE tissue and shed light on unexplored areas of clinical research that are beyond the reach of current technologies.